Mountain States Advancement in Research, Supportive Networking and Career Development (ASCEND)

PROFESSIONAL DEVELOPMENT CORE – PROJECT SUMMARY
The mission of the ASCEND Professional Development Core is to help predoctoral and postdoctoral
trainees (Ph.D. and M.D.) acquire the skills and experiences needed to successfully transition into their careers
in KUH research. Trainees will deepen and expand their professional skill sets to enhance their current role,
equip them to become independent KUH research scientists, and broaden their career horizons. Our program
at the University of Colorado (CU) and University of Utah (UU) is designed to promote individualized training to
facilitate each trainee’s professional development to encourage trainees to take ownership of their career and
identify opportunities to work towards their specific career goals. In the ASCEND program, we will strive to
supplement our world-class research training with world-class “non-bench” training, making our trainees highly
sought after for KUH scientific positions. James Hotaling, MD (UU Urology) will serve as Core Director and
Mary Weiser-Evans, PhD (CU Nephrology) will serve as Co-Director. Dr. Hotaling is an Associate Professor of
Surgery and Associate Vice President for Research Innovation and Translation. He has been a significant
driver in reshaping research training within Urology at UU. Dr. Weiser-Evans is a Professor of Medicine and
Vice Chair of Research for the Department of Medicine at CU. She has significant experience as an educator
and in the development and leadership of training programs. She is also a Center for the Improvement of
Mentored Experiences in Research (CIMER) Principal Facilitator and will play a critical role in implementing
ASCEND mentor training. We propose the following aims: 1) Provide a structured curriculum that provides
support, guidance, and protected time for trainees to engage in professional development. We will implement a
cohort-based structured program that will be composed of dedicated didactics, workshops, cross-disciplinary
seminars, and online resources; 2) Promote active trainee engagement in professional career development to
enhance skill development, career exploration, satisfaction, and planning to become an independent KUH
researcher. All trainees will complete Individual Development Plans annually. Trainees will meet monthly with
their mentoring team and will meet yearly with a career counselor to refine career goals; 3) Equip faculty
mentors and trainees with the skills to develop meaningful and productive mentoring relationships to ensure
successful career development and transitions of trainees. In collaboration with the TL1 Training Core and the
Network Core, we will develop the ASCEND Co-mentoring program to address the specific needs of faculty
mentors and trainees. Successful completion of our aims will allow trainees to be better prepared to navigate
their research careers as the research workforce grows and the career landscape changes as well as become
better KUH leaders, managers, and mentors, independent of their research setting.